CHEMISTRY SUPPORT SERVICES--NATIONAL TOXICOLOGY PROGRAM

Provide continuous chemistry support services for the National Toxicology Program to include chemical procurement and synthesis, bulk chemical characterization, and dosed vehicle preparation and analysis.